Sex differences in the contribution of cerebrovascular injury and immune activation to neurocognitive impairment in HIV infection

PROJECT SUMMARY
Neurocognitive impairment (NCI) affects up to 50% of persons living with HIV (PWH), including individuals with
well-controlled infection. Biological sex is an important determinant of NCI among PWH. The strongest
available evidence indicates that women with HIV have greater cognitive deficits globally than men with HIV
and, most prominently, in learning, memory, and processing speed. Although women make up half of the
world’s HIV population, few studies have focused on the mechanisms underlying sex differences in the
prevalence and pathogenesis of NCI in PWH, despite the consequences that these differences could have on
developing distinct therapeutic approaches to NCI for women and men.
At least two pathways may differentially impact cognitive health in women and men with HIV, both through their
association with cerebrovascular injury: (1) cardiovascular disease (CVD) risk factors and (2) immune
activation and inflammation. Our central hypothesis is that NCI is more prevalent in women with HIV than in
men with HIV due to greater burden and progression of cerebrovascular injury from increased susceptibility to
the effects of CVD risk factors and immune activation. In Aim 1, we will determine if sex modifies the
association of CVD risk factors and immune activation with cerebrovascular injury in PWH. In Aim 2, we will
compare the burden and progression of cerebrovascular injury between women and men with HIV. In Aim 3,
we will examine the extent to which cerebrovascular injury mediates the higher prevalence of NCI and decline
in women with HIV and if sex modifies the association between cerebrovascular injury and NCI.
To achieve our aims, we propose a prospective study that will leverage the research platform provided by the
NIH-funded Multicenter AIDS Cohort Study (MACS)/Women’s Interagency HIV Study (WIHS) Combined
Cohort Study (MWCCS). We will enroll 150 women (100 post-menopausal and 50 pre-menopausal women)
and 100 age-matched men from the MWCCS to ensure the study is adequately powered to determine if sex
modifies the associations between CVD risk factors, immune activation, cerebrovascular injury, and NCI. To
the longitudinal neuropsychological data and stored blood specimens collected in the MWCCS study, we will
add a comprehensive cerebrovascular imaging assessment, including of cerebral vasoreactivity, large artery,
and small vessel disease, that will yield a complete profile of cerebrovascular injury. We will also measure
immune activation and inflammatory markers that are associated with both cerebrovascular injury and NCI in
PWH and have been shown to be higher in women compared with men. The findings of this study will provide
new information on sex differences in the burden and progression of cerebrovascular disease and in the
pathogenesis of NCI in PWH, which will inform the rational design of clinical trials, including the target study
population, in which to test interventions to prevent and treat NCI in PWH.

Public health relevance
PROJECT NARRATIVE Neurocognitive impairment (NCI) in persons living with HIV infection (PWH) is a major public health challenge that is expected to grow as PWH reach older age. This proposal will determine whether women with HIV are more vulnerable to NCI than men with HIV due to greater burden and progression of cerebrovascular injury from increased susceptibility to the effects of CVD risk factors and immune activation. Understanding sex differences in the mechanisms driving the development of NCI in PWH will inform the rational design of clinical trials of preventive and therapeutic strategies optimized by sex.